ATP-dependent and independent mechanisms of regulating chromatin states

PROJECT SUMMARY/ABSTRACT N/A – Project Summary/Abstract will not change.

Public health relevance
PROJECT NARRATIVE N/A – Project Narrative will not change.